Continuous Glucose and Fetal State Monitoring: A Novel Approach to Understanding Neurodevelopmental Trajectories in Gestational Diabetes

ABSTRACT
My research program focuses on leveraging novel technologies to study the influence of maternal metabolism
on fetal behavior during pregnancy, with a focus on understanding early biomarkers of fetal-to-infant
neurodevelopment. The proposed project will implement innovative wearable devices to study the impact of
maternal glucose on fetal development pathways through which typical and atypical physiology and metabolic
exposures shape fetal neurodevelopmental trajectories. My training to date has provided me with a strong
foundation of skills in developmental psychology, infant neurobehavioral assessment, fetal to infant
electrophysiology, and biomarkers related to early life experiences. To effectively establish and lead my research
program I require additional training on glucose metabolism during pregnancy, advanced deep learning
techniques to analyze complex continuous data, and additional mentoring on working with term and preterm
neonates in a research setting. By engaging in this protected training time, I will enter my independent stage of
research well prepared to lead a research team studying the impact of fluctuations in maternal glucose on fetal
behavior and autonomic maturation and their long-term influence on neurodevelopmental trajectories. Research
Project: Exposure to gestational diabetes in utero is associated with an increased risk for infant
neurodevelopmental delays and psychiatric disorders. While neurodevelopment begins in utero, we lack critical
knowledge about sensitive periods and mechanisms that contribute to increased vulnerability in affected
offspring. This K99/R00 project aims to fill this gap by examining how maternal glucose fluctuations, assessed
via continuous glucose monitoring (CGM), impact the development of fetal behavioral states and autonomic
regulation in healthy and hyperglycemic pregnancies, and how these may predict neurodevelopmental risks in
infancy. During the K99 phase, we will employ deep learning techniques to analyze how gestational diabetes
affects sequential and temporal patterns of fetal heart rate, measured via fetal electrocardiogram (fECG), to
evaluate fetal behavior and autonomic maturation (Aim 1). Additionally, we will examine how GDM affects the
development of cyclicity and stability of fetal sleep-wake cycles in continuous overnight recordings (Aim 2). The
R00 project will investigate how typical and atypical fluctuations in maternal glucose throughout pregnancy shape
the development of fetal behavioral states and autonomic control, with neurobehavioral evaluation extending to
6 months after birth (Aim 3). By integrating wearable technologies such as CGM and fECG for continuous,
naturalistic assessments, this project offers an unprecedented opportunity to capture the impact of glucose
fluctuations on fetal behavior. This approach will lay a foundation for identifying sensitive periods, underlying
mechanisms, and early indicators of neurobehavioral trajectories.

Public health relevance
NARRATIVE Exposure to gestational diabetes is closely associated with adverse neurodevelopmental outcomes, yet our understanding of the underlying mechanisms and their role in shaping perinatal trajectories remains limited, largely due to the inherent inaccessibility of the fetus. This project leverages wearable technologies to examine how fluctuations in maternal glucose affect fetal behavioral states and autonomic regulation during pregnancy, while the fetus is exposed to altered metabolic conditions. By understanding how metabolic exposures shape fetal development, this research has the potential to inform public health strategies to identify and address neurodevelopmental vulnerabilities before birth.